Regulation of Mitochondrial Lipid Homeostasis by mTORC1

Project Summary/Abstract
Mechanistic target of rapamycin complex 1 (mTORC1) is a major cytosolic regulator of cellular anabolism and
governs many downstream metabolic processes. Mitochondria are semi-autonomous organelles that are major
hubs of compartmentalized biochemical reactions within cells. While the role of mTORC1 in coordinating
metabolic balance in the cytosol are consistent with its ability to sense and respond to perturbations in the
cellular nutrient state, the effect of mTORC1 on mitochondria remain poorly defined.
To identify how mitochondria are impacted by loss of mTORC1 signaling, I performed quantitative proteomic
analysis on immunopurified mitochondria from cells treated with mTORC1 inhibitors and identified several
proteins involved in mitochondrial lipid homeostasis. We identified PRELI Domain Containing 1 (PRELID1) as
an essential, short-lived mitochondrial protein that is downregulated upon mTOR inhibition. While mTORC1 is
active in the cytosol, it remains unclear how the stability of PRELID1 in mitochondria is affected. In my
preliminary work, I identified that inhibition of proteasome function protects PRELID1 against degradation
induced by mTOR inhibition. To identify the genes responsible for this phenomenon, I developed a
CRISPR/Cas9 genetic screening approach to individually knock out components of the Ubiquitin-Proteasome
system (UPS) and interrogate how mTOR status in the cytosol maintains stability of PRELID1. The top-scoring
gene in my preliminary genetic screen was Seven in Absentia Homolog 1 (SIAH1), an E3 Ubiquitin ligase with
previously reported mitochondrial targets. I hypothesize that mTORC1 regulates mitochondrial lipid
homeostasis, in part, through the action of SIAH1 and that this axis may be a suitable drug target in metabolic
diseases such as nonalcoholic fatty liver disease (NAFLD). A lack of insight into the mechanistic role of
mTORC1 in regulating mitochondrial function precludes investigation of this hypothesis.
In this proposal, building on my preliminary work, I will test the hypothesis that mTORC1 regulates
mitochondrial function by regulating the lipid composition of mitochondria. In Aim 1, I will investigate the
mechanism by which mTORC1 regulates mitochondrial lipid homeostasis. In Aim 2, I will determine how
mTORC1 orchestrates mitochondrial lipid homeostasis in mouse liver models and the role cardiolipin plays in
the pathogenesis of NAFLD. I anticipate that these studies will determine: 1) the mechanistic role of SIAH1 in
shaping mitochondrial function under metabolic stress and 2) the contribution of mitochondrial dysfunction to
the development and progression of NAFLD. The work and training plan outlined in this proposal will be
completed in the laboratory of Dr. Kivanc Birsoy at the Rockefeller University and will best prepare me for a
career as an independent academic physician-scientist.

Public health relevance
Project Narrative Nonalcoholic fatty liver disease (NAFLD) affects nearly 30% of the global and U.S. populations, often progressing to cirrhosis or hepatocellular carcinoma if untreated. The Mechanistic Target of Rapamycin Complex 1 (mTORC1), a critical metabolic sensor, is implicated in the pathogenesis of NAFLD, yet its effects on mitochondria, one of the most metabolically active cellular organelles, remain unclear. This study aims to elucidate how mTORC1 activity modulates mitochondrial function and how the mTOR-mitochondria axis contribute to the development of NAFLD, with the goal of identifying potential therapeutic targets for NAFLD, a disease lacking FDA-approved treatments.